Microvascular endothelial Kir channels in flow-induced dilation and hypertension

Abstract:
Flow-induced vasodilation (FIV) is a hallmark of the endothelial response to flow and an
essential mechanism for the control of blood flow to the microcirculation. It is well established
that a key mechanism responsible for FIV is generation of nitric oxide (NO). Our recent study
discovered that FIV and flow-induced generation of NO in resistance arteries of mice and
humans critically depend on endothelial inwardly-rectifying K+ channels (Kir2.1). We also
established that Kir2.1 regulate endothelial NO synthase (eNOS) via a serine/threonine kinase
Akt1. This was particularly interesting and important because Kir channels have long been
known to be sensitive to shear stress but their role in endothelial responses to flow remained
unknown. The goals of this proposal are to determine the mechanisms by which Kir2.1 channels
couple hemodynamic shear stress forces to activation of endothelial NO synthase (eNOS) and
NO production and to evaluate the role of endothelial Kir channels in vasoreactivity of human
vessels in hypertension. Our first aim is to elucidate the mechanism responsible for the
sensitivity of Kir2.1 channels to shear stress, which is currently completely unknown. Our
preliminary data show that flow-sensitivity of Kir2.1 is abrogated by enzymatic degradation of
Heparan Sulphate (HS)-Glycocalyx and reduced in ECs isolated from Sydecan1-/- mice. We
propose, therefore, that flow-induced activation of Kir channels is mediated by the endothelial
Glycocalyx, specifically Syndecan-1, and possibly other elements of HS-Glycocalyx. We also
propose that Kir2.1 interacts directly with Syndecan-1, and elucidate the mechanism of this
interaction. Our second aim focuses on the mechanism that couples Kir2.1 to the downstream
Akt1 signaling pathway. It is well-known that flow-induced activation of AKT1 requires its
translocation and recruitment to the membrane via association with a phospholipid PIP3. We
propose that Kir enhances the association of Akt1 with PIP3 and thus facilitates its recruitment
to the membrane, resulting in increased Akt1 phosphorylation. We also explore the possibilities
that flow-induced activation of Kir2.1 may regulate the upstream events, such as activation PI3K
and its recruitment to VEGFR2 mechanosensing complex or inhibit a phosphatase PTEN that
converts PIP3 to PIP2. This signaling mechanism is explored in primary endothelial cells and in
intact resistance arteries freshly-harvested from mice. A new endothelial-specific inducible
mouse model of Kir2.1 deficiency has been generated in our lab to achieve these goals. In aim
3, we propose to test the hypothesis that microvascular endothelial Kir function is depressed
during human hypertension. This aim is based on our preliminary data showing decreased
contribution of Kir2.1 to FIV in a pilot cohort of hypertensive patients. In this study, we will recruit
3 groups of subjects that include patients with pre-hypertension or stage 1 hypertension and
healthy controls. We will also determine whether the loss of Kir2.1 contribution to FIV should be
attributed to the loss of the functional expression of Kir2.1 channels or to their impaired coupling
to the downstream signaling. Finally, we will also determine whether impaired FIV in
hypertensive patients may be rescued by restoring Kir2.1 activity.

Public health relevance
Narrative: Control of blood pressure is a fundamental mechanism required for normal vascular function and impairment of the mechanisms that control blood pressure leads to hypertension. Hypertension is extremely prevalent and hypertension-related cardiovascular disease is one of the leading causes of morbidity and mortality in the US. We have recently discovered a new mechanism that contributes to the dysfunction of vascular endothelium, an inner lining of the blood vessels, which is well known to play a key role in the regulation of vascular tone. Specifically, we found that a specific type of endothelial potassium channels, Kir, is a key contributor to endothelium-induced relaxation (vasorelaxation) of resistance blood vessels, an essential mechanism for control of blood pressure. Furthermore, our preliminary observations suggest that impairment of Kir channels maybe related to the development of hypertension. In this study, we focus on elucidating the basic mechanism of how Kir channels contribute to endothelium-dependent vasorelaxation and explore the role of Kir in the early stages of hypertension.